Causal inference of common and personalized single-cell gene regulatory networks

PROJECT SUMMARY
Gene regulatory networks (GRNs) underpin cell identity, function, and response to external stimulations in
human health and disease. Their systematic reconstruction from data not only promises to understand disease
mechanisms at the molecular level in basic science, but also directly assists the translational search for
therapeutic targets and disease subtypes.
An accurate GRN reconstruction requires two driving factors – data and method. For data, single-cell
technology has presented a unique opportunity for data volume and cell type specificity, but also suffers from
severe challenges in sparsity and scalability. In addition, every GRN is heavily influenced by the genetic and
epigenetic variations that differ greatly between individuals and cell types. This limits the utility of most existing
GRNs, which were reconstructed from the data of cell lines or very few donors, in primary cells and the whole
population. In terms of GRN reconstruction method, causal inference holds great promise in its capacity to
accurately identify causation from reverse causation and confounding, and therefore reproducibly estimate
perturbation outcomes for therapeutic development. However, mainstream causal inference methods face
major challenges in GRN reconstruction, falling short in modeling causal kinetics, feedback loops,
measurement noise, and GRN rewiring that are widespread in complex biological systems and measurements.
We will overcome the data challenges by reconstructing GRNs for each primary cell type/state using 1)
population-scale and 2) atlas-scale single-cell datasets that include numerous individuals of the whole
population. This project will be built on and extend our recent novel causal inference framework using
stochastic differential equations and probabilistic modeling to address the method challenges. We plan to
demonstrate their utility in the therapeutic control of gene expression levels. We will release our
methodological advances as open-source software and our causal GRNs as a public resource. We expect
them to provide the community with comprehensive molecular network knowledge and perturbation outcome
prediction to promote disease mechanism understanding and therapeutic target discovery. This will become a
part of our long-term goal in generating a full map of multi-modal causal molecular circuits from publicly
available data in single-cell and spatial omics.

Public health relevance
PROJECT NARRATIVE Genes control each other’s function in a complex network pattern in individual cells. They are the fundamental driving force of complex diseases and traits. This research seeks to enhance understanding of these complex networks. In this proposal, we will develop advanced methods for this task to reverse engineer these complex networks. Such insights could lead to improvements in existing therapies, providing higher efficacy and lower adverse effects.